NET stabilization: mechanistic and therapeutic studies studying the role of NETs in thromboinflammatory disease

ABSTRACT
In response to inflammatory stimuli, neutrophils (PMN) release neutrophil extracellular traps (NETs), webs of
negatively-charged cell-free (cf) DNA complexed with positively-charged histones, which capture pathogens.
However, the release of NETs (NETosis) can inflict tissue damage on the host and has been implicated in the
severity of conditions like sepsis, linked with acute NETosis, and sickle cell disease (SCD), associated with
chronic NETosis. While many advocate for treatments degrading NETs or inhibiting NETosis, these approaches
may inadvertently release endothelial-damaging NET-degradation products (NDPs) or increase susceptibility to
infection. An alternative strategy is NET stabilization—wherein NETs are preserved but modified to bolster
microbial capture and diminish NDP release. This approach may be therapeutic in both sepsis and SCD. Platelet
factor 4 (PF4) is a positively-charged chemokine released by activated platelets that binds to and cross-
aggregates polyanions like heparin and DNA. PF4 similarly binds to NETs, causing them to become physically
compact and resistant to nuclease digestion. PF4 also binds to negatively-charged molecules on the bacterial
surface and markedly enhances their capture by NETs. An Fc-deglycosylated murine monoclonal antibody
(moAb) targeting human PF4 complexed to polyanions enhances PF4's protective effects, improving survival in
murine sepsis models. This proposal is designed to fill knowledge gaps in our understanding of the role of NETs
in host defense to define when NETs should be preserved, providing justification for further exploration of NET-
stabilizing therapeutics, such as PF4 and Fc-modified anti-PF4:polyanion antibodies. Specific Aim (SA) #1:
Characterize the role of NETs in immune homeostasis. This aim is structured to clarify the role of NETs in
host defense, exploring how impaired NETosis alters inflammatory cytokine levels, PMN gene expression, and
gut microbiome composition in murine models. The impact of these changes on enteric bacterial pathogenicity
and murine survival will be assessed using a polymicrobial sepsis model to clarify the role of NETs in host
defense. SA#2:Define the mechanism by which PF4 and Fc-modified KKO limit bacterial dissemination.
Studies in this aim will define the mechanisms by which PF4 and anti-PF4:polyanion antibodies enhance NET-
mediated bacterial capture and determine whether these interventions promote bacterial killing. Comparative
studies of KKO variants will be conducted in vitro and in murine infection models utilizing bacterial strains with
variation in surface electrostatic charge. Murine studies will examine how different interventions affect the release
of NDPs, bacterial dissemination, and microvascular damage. SA#3:Investigate the potential of NET-directed
therapeutics in SCD. The final aim will investigate the use of NET-directed therapeutics in SCD, examining their
potential to prevent endothelial cell injury and reduce bacterial infection risk. Patient plasma samples will be
analyzed for NET levels, NDP concentrations, and endothelial cell damage markers, and therapeutic efficacy
will be evaluated in an endothelial-lined microfluidic system.

Public health relevance
PROJECT NARRATIVE Neutrophils, a class of white blood cells that combat bacteria, can become overactive in overwhelming infection and an inflammatory condition called sickle cell disease, releasing anti-bacterial compounds that contribute to life-threatening organ damage. I propose a new therapy that neutralizes these dangerous compounds while also improving neutrophils’ ability to control infections. My goal is to further understand how this strategy works and to bring it to patient care to improve outcomes in conditions complicated by over active neutrophils including bacterial infection and sickle cell disease.